Program Project – Improving Provider Announcement Communication Training (IMPACT)

ABSTRACT – Overall
Widespread HPV vaccination in the US could prevent 32,100 cancers every year. Despite this tremendous
potential, HPV vaccination coverage is far short of the nation's goal of 80%. Provider recommendations are
uniquely powerful in increasing HPV vaccine uptake. However, primary care teams and healthcare systems
face barriers to effective HPV vaccine communication, and many questions remain unanswered about how to
increase the potency of provider recommendations. We propose the P01 Program Project, “Improving Provider
Announcement Communication Training (IMPACT).” The goal of IMPACT is to improve HPV vaccine
communication and uptake among adolescents. IMPACT's specific aims are to 1) Identify opportunities to
improve HPV vaccine communication; 2) Evaluate the impact and cost of HPV vaccine communication
interventions in cluster randomized clinical trials; and 3) Support implementation of HPV vaccine
communication interventions in healthcare systems. The IMPACT Program Project's shared theme is
amplifying the impact of a Research-Tested Intervention Program to improve HPV vaccine
communication in healthcare systems. The projects will work together to enhance the impact of the
Announcement Approach Training (AAT), an HPV vaccine communication training for primary care
professionals, which received designation as a Research-Tested Intervention Program (RTIP) from the
National Cancer Institute. Project 1 will establish how to involve the whole primary care team in HPV vaccine
recommendations. The project will examine whether optimizing the use of standing orders support increases
HPV vaccine uptake in clinics receiving the AAT. Project 2 will examine what motivates providers to
recommend HPV vaccination. The project will establish whether clinic-level financial incentives increase
vaccine uptake in clinics receiving the AAT. Project 3 will examine who should facilitate the trainings. The
project will establish whether engaging clinical champions in healthcare systems to implement the AAT within
their own systems increases vaccine uptake. Project 4 will examine which interventions fit systems' resources.
The project will examine the budget impact, cost-effectiveness, and population health impact of HPV vaccine
interventions in rural and nonrural communities and aid decision makers with a decision support tool to
facilitate the adoption of promising interventions. The research projects will receive support from 3 cores:
Administrative, Data, and Intervention. IMPACT's activities will culminate with the creation of the AAT
Intervention Package to support improving HPV vaccine uptake in healthcare systems. Throughout the
proposed Program Project, the shared theme and AAT focus will create synergies among the projects and
cores that generates significant and novel scientific insights into how to improve HPV vaccine communication
and uptake. Our approach will also accelerate the evolution of communication trainings for primary care
professionals, accomplishing in 5 years what might otherwise take two decades.

Public health relevance
NARRATIVE – Overall The Program Project's goal is to improve HPV vaccine communication and coverage in healthcare systems, a critically important opportunity for cancer prevention. We will create a package of intervention modules to accelerate improvements in HPV vaccine communication and uptake in healthcare systems.